Prescription opioids, brain structure, and cognition in older adults with chronic pain

Project Summary/Abstract
Chronic pain is experienced by more than 30% of older adults (>65 years of age), many of whom receive
prescription opioids despite well-described adverse effects including gastrointestinal distress, constipation,
physical dependence, and respiratory depression. More recently, longitudinal observational studies led by our
group and others have highlighted that prescription opioids are associated with accelerated cognitive decline in
older adults, including increased risk for mild cognitive impairment or dementia. However, two critical gaps
remain in our understanding of the relationship between prescription opioids and cognition. First, existing
observational studies are unable to adequately distinguish the effects of opioids from those of underlying
chronic pain necessitating opioids (i.e., confounding by indication). Second, the biological mechanisms driving
the relationships between opioids and cognition are unknown. We find in prior work that prescription opioids
are associated with decreased white matter integrity in major axonal pathways, including the corpus callosum
and other pathways integral to cognitive and emotional processing. These findings are consistent with
preclinical studies showing the opioids impair myelin production by oligodendrocytes. However, as with
cognition, these observational data cannot be used to distinguish the potential causative effects of opioids from
the effects of underlying pain. The overall purpose of this project is to test the hypothesis that opioid-mediated
impairments in myelin production and/or other direct or indirect effects on axonal integrity mediate opioid-
associated cognitive impairment. We will conduct a single-center, double-blinded, placebo-controlled trial
including 200 participants with chronic pain secondary to osteoarthritis. The primary aim is to determine
whether exposure to prescription opioids is associated with brain structural changes on magnetic resonance
imaging (MRI), with the primary outcome of white matter integrity as measured by fractional anisotropy of the
corpus callosum. The secondary outcome will be global cognition. Exploratory outcomes include several
patient-centered outcomes (mental health, physical function, quality of life, sleep). All participants will receive
evidence-based, tiered interventions to treat their pain under the direction of the study team (experts in pain
management for older adults). In addition, they will be randomized to receive either opioids or placebo over a 6
week treatment period with titration of study medication based on pain scores per a defined protocol. All
participants will undergo MRI imaging at enrollment and again at 12-months to evaluate the primary outcome.
Participants will also undergo neurocognitive testing and assessment of exploratory patient-centered outcomes
(e.g., quality of life). Our team has the requisite experience and expertise to perform this innovative research,
whose findings will have a major impact on clinical practice and shared clinical decision making, regardless of
study results.

Public health relevance
Project Narrative Prescription opioids are associated with brain structural changes and cognitive impairment in older adults,1–4 yet existing studies are unable to distinguish effects of opioids from underlying chronic pain.5 Further, the biological mechanisms driving these relationships are unknown. Our preliminary data suggest that opioids may impair white matter integrity in major axonal pathways important for cognitive and emotional processing.6 In this work, we propose a placebo-controlled, double-blind, randomized clinical trial of prescription opioids vs placebo, incorporated with advanced pain care, for older adults with chronic pain secondary to osteoarthritis, evaluating the impact of opioids on brain morphometry (primary), cognition (secondary), and patient-centered (exploratory) outcomes.